PARITY: An integrated community care and strengths-based technology intervention to improve maternal wellness and reduce health disparities in Black women

Project Summary
In the United States, excessive rates of maternal morbidity and mortality are a public health crisis borne
disproportionately by Black women. Decades of research have failed to ameliorate this crisis. Most research
involving Black maternal morbidity and mortality is structured according to a deficit-focused framework,
which highlights the deficiencies and insufficiencies of individuals within the examined community. Clinical
practices resulting from such research normalize and blame individuals for the maternal health disparities
that Black women experience. This proposal addresses maternal morbidity and mortality and the impact of
deficit-focused health care models on maternal health by leveraging the protective assets of Black
communities and individuals, use of integrated supportive care, and a wellness-based mobile technology
intervention to reduce maternal morbidity, mortality, and cesarean birth and improve wellness-related
behavioral outcomes. Our goal is to offer pragmatic, community-centered solutions to maternal health
disparities that build upon the inherent strengths of Black individuals and Black communities . Based on our
theory of maternal adaptive capacity and building upon our previous work, we have developed a novel
program called Protective Assets Reinforced with Integrated care and TechnologY (PARITY). We propose a
randomized trial and mixed methods evaluation involving 384 Black pregnant women, divided between PARITY
program participants and information control (IC). Our innovative, community-based intervention will identify
the strengths and protective assets of intervention participants and of their communities. Within the
community setting, PARITY participants are matched with Black doulas who will provide strengths-based
guidance, support, and community resources throughout the pregnancy continuum. PARITY participants will
also use a novel HIPAA compliant mobile technology platform that promotes wellness behaviors,
empowered strengths, and healthcare adherence while offering additional opportunities to connect with the
community-based doula. The specific aims of this proposal are: (1) Determine the effects of the PARITY
program, as compared to IC, on severe maternal morbidity (primary outcome), maternal mortality, and cesarean
birth (secondary outcomes) in Black pregnant women; (2) Determine the effects of the PARITY program on
wellness-related behavioral outcomes including nutrition, physical activity, sleep, and healthcare adherence; (3)
Assess whether changes in maternal outcomes are mediated by changes in wellness-related behavioral
outcomes and whether the effects of PARITY on the wellness-related behavioral outcomes are mediated by
changes in empowered strengths; and (4) Identify barriers, facilitators, and perceived benefits of the PARITY
intervention. The proposed research offers a comprehensive, innovative approach to maternal morbidity and
mortality reduction by integrating a strengths-based framework, novel technology, and peer-based community
support, while addressing healthcare access, healthcare quality, and the social needs of each participant.

Public health relevance
Project Narrative Despite decades of research, the United States continues to experience a crisis in severe maternal morbidity (SMM) which disproportionately impacts Black women. Based on the Theory of Maternal Adaptive Capacity, this proposal uses a novel intervention that emphasizes the protective assets of individuals and communities, utilizes community-based Black doula support, and a mobile technology wellness platform to reduce SMM and improve maternal wellness. The proposed research will provide an innovative solution that promotes healthcare access, healthcare quality, and social conditions to improve maternal outcomes for Black women.